Investigating Estrogen-Mediated Signaling in Binge Drinking Microcircuits of the Prefrontal Cortex

PROJECT SUMMARY/ABSTRACT
Binge drinking among women presents a significant public health crisis, with both binge and heavy
alcohol use among women surging over the past decade. Alcohol Use Disorder (AUD) is characterized by the
presence of two or more clinical criteria indicating a sense of losing control over drinking habits. Estrogen (E2)
levels are correlated with binge alcohol consumption levels across species, and repeated findings of menstrual
cycle follicular/ovulatory phase and peak E2 promoting alcohol consumption are a strong argument for a
mechanistic role in E2 for potentiating alcohol consumption in humans. Despite this, the mechanistic role of E2
in the sex differences in binge drinking behaviors driven by microcircuits of the prefrontal cortex (PFC) remains
understudied. This fellowship proposes a comprehensive investigation into how E2 signaling influences binge
drinking microcircuits of PFC somatostatin (SST) neurons in mice, through the following aims:
Aim 1: Leveraging single molecule fluorescence in situ hybridization (RNAscope) and serum E2
measurements, transcriptional profiles of estrogen receptor α (ERα; Esr1) and β (ERβ; Esr2), Sst, and CaMKIIa
in PFC neurons across the estrous cycle and following binge alcohol exposure will be assessed for their correlation
with alcohol consumption with the voluntary Drinking in the Dark (DID) binge alcohol model.
Aim 2: Whole-cell patch-clamp recordings of ex vivo SST-Ai9 brain slices will be assessed for changes in
intrinsic excitability across estrous stages, and membrane potential with exogenous E2 after binge alcohol
consumption. Furthermore, isotype specific estrogen receptor antagonists will be used to separate the
contribution of ERα versus ERβ on changes in membrane potential with E2 bath application.
Aim 3: Viral-mediated shRNA knockdown of ERα and ER expression specifically in PFC SST neurons
will reveal the impact of ERα/ levels on binge alcohol consumption in female mice. This approach will allow
direct assessment of the role of ERα/ in modulating alcohol consumption behavior.
By integrating these approaches across transcriptional, electrophysiological, and behavioral levels of
analysis, the proposed aims will provide a comprehensive understanding of how E2 signaling influences binge
drinking microcircuits within the PFC. This research has significant implications for developing targeted
interventions for alcohol use disorder, particularly in women, and underscores the importance of considering
sex-specific hormonal influences in addiction research and treatment.

Public health relevance
PROJECT NARRATIVE Recent surveys show increasing levels of alcohol consumption and binge drinking in women in the United States. Evidence suggests a significant role for estrogen in modulating alcohol consumption patterns in both humans and animal models, as the hormonal fluctuations of the menstrual cycle have been linked to probability of binge drinking behaviors in humans and ovarian hormones are known regulate some brain reward circuitry in female mice. The results of this proposal will progress our understanding of the influence of estrogen on alcohol use disorder to pave the way for targeted hormonal recommendations for women with Alcohol Use Disorder.